Dissecting the cellular interplays of adipose tissue remodeling in the regulation of insulin sensitivity

PROJECT SUMMARY/ABSTRACT
This proposed career development award will provide Dr. Diana Alba MD with targeted mentored training
to ensure she develops into an independent researcher utilizing both experimental approaches and models, and
“omics” coupled with bioinformatic tools, to probe the mechanisms linking obesity to adipose tissue dysfunction
and diabetes. In certain individuals, adipose tissue is dysregulated in obesity, and this is an early mediator of
diabetes pathogenesis. However, precisely what underlies this dysfunction is not well-defined. Subcutaneous
white adipose tissue (sWAT) fibrosis is associated with insulin resistance, whereas the abundance of heat-
generating brown-like adipocytes in sWAT (“beiging”) is linked to metabolic health. The proposed research plan
aims to close key knowledge gaps regarding the reciprocal influences of sWAT fibrosis and beiging on insulin
sensitivity. To do so, the PI will take advantage of an innovative human cohort containing individuals with widely
divergent levels of both sWAT fibrosis and insulin sensitivity and use this resource to comprehensively probe
key cellular constituents and molecular pathways that shift sWAT away from being influenced by beige
adipocytes to developing fibrosis and insulin resistance. The PI aims to 1) identify transcriptional signatures
across cell types in the sWAT that coordinately modulate WAT fibrosis, body fat distribution, and glucose
homeostasis, 2) probe reciprocal influences of sWAT beige activity and fibrosis on insulin sensitivity via
transcriptional regulation, 3 ) use the BXD panel of recombinant inbred mice as an orthogonal genetic reference
to model divergent patterns of fat distribution and validate the mechanistic relevance of pathways and cell types
identified in the humans studies.
The proposed 5-year career development and training plan incorporates strategically designed didactic
learning, mentored practical training, and career advising to complement the PI’s expertise in ways that are critical
to completion of her research and career goals. The specific career development goals outlined in this
application include developing mechanistic expertise in 1) adipose tissue biology through hands-on molecular
and computational biology training; 2) metabolic assessment of mouse models; 3) the human translation of
adipose tissue biology including multi-omics and metabolic phenotyping. She will be training at UCSF, a world-
class center for basic and translational research and an excellent environment for physician-scientist training
with experts in all aspects of the proposed training. She will be closely mentored by Dr. Suneil Koliwad, an expert
in inflammation, nutrition, and glucose/energy metabolism, and Dr. Shingo Kajimura, an expert in adipogenesis
and beige fat. The long-term goal is to provide Dr. Alba with the skills required to become an independent, R01-
funded faculty member working to identify adipose tissue disease-relevant mechanisms and risk markers for
diabetes, particularly in high-risk populations, and elucidate targets to specifically mitigate insulin resistance.

Public health relevance
PROJECT NARRATIVE Both obesity and consequent diabetes are highly prevalent worldwide, and given their profound impact on morbidity and mortality, limiting these conditions is a major health challenge of our time. This proposal seeks to address critical knowledge gaps in our mechanistic understanding of the molecular and cellular factors driving a process termed fat “fibrosis”, which we showed is associated with insulin resistance in humans, and the extent to which these factors reciprocally govern an alternative process, termed “beiging”, which is associated with metabolic health and insulin sensitivity. The knowledge we gain from this mechanistic inquiry, which will be undertaken using an innovative human fat tissue repository as well as strategically designed mouse models, may be broadly applied to determine clinically relevant links between obesity and diabetes.